Cooperative Agreement for ODA conformance with Manufactured Food Regulatory Progr

Project Summary/Abstract The Oregon Department of Agriculture's (ODA) objective relative to the Manufactured Food Regulatory Program Standards (MFRPS) is to develop and maintain an integrated system that requires and tracks compliance with food safety laws and regulations to ensure food safety and consumer protection. ODA's progressive implementation of MFRPS will facilitate the design, assessment and improvement of such a system. ODA regularly partners with the Food and Drug Administration (FDA) to regulate Oregon's food establishments. In 2007, ODA enrolled in the MFRPS program as a pilot state, and has continued to participate in the program since that time. ODA's current contract with FDA commits ODA to conduct 600 general Good Manufacturing Practices (GMP) inspections; however, ODA has conducted as many as 750 GMP inspections in a year. ODA intends to maintain its commitment to conduct contract inspections throughout the term of the Cooperative Agreement. Over the next five years, ODA intends to fully implement MFRPS by developing methods to measure effectiveness of implementation and by making continuous improvements. ODA intends to participate in on-site FDA visits and meetings and to provide FDA access to ODA records, databases and other materials. Since 2007, ODA has been creating an improvement plan that clearly outlines objectives and tasks, timelines for completion, resources assigned and personnel involved. When completely implemented, the plan will result in significant to full conformance with MFRPS standards. ODA has committed substantial amounts of its own resources to upgrade its computer operating system; including its inspection program and all MFRPS related fields. ODA is working diligently to provide a structure that is both manageable and sustainable. However, the MFRPS program is time consuming and requires substantial resources for its maintenance. This Cooperative Agreement will help to provide ODA with the resources necessary to develop a sustainable system, allowing ODA to maintain compliance with MFRPS into the future.

Public health relevance
Project Narrative The Oregon Department of Agriculture's (ODA)'s primary mission is to ensure food safety and to provide consumer protection. In accordance with this mission, ODA commits to implement and sustain conformance, to the fullest extent possible, with the Manufactured Food Regulatory Program Standards (MFRPS). By employing the MRRPS standards, ODA will more rapidly identify threats to public health; shorten response times, thereby reducing the likelihood of harmful products being manufactured and distributed; and strengthen its collaboration with the Food and Drug Administration and other partners. __SpecificAimsTextDelimiter__ Specific Aims Goal As a recipient to this Cooperative Agreement, ODA's principle goal will be to utilize the funds to achieve and sustain significant to full conformance with the MFRPS within five years. Expected Outcomes ODA will implement the MFRPS in a sustainable fashion that can be maintained and updated to meet future needs and requirements. ODA views its implementation of the MFRPS program as a critically important step for the state, in order for it to create and foster a food safety program that can be fully integrated into a national food safety system. Adherence to the MFRPS will help ODA become a viable part of a national food regulatory system that will build cooperation and consensus across regulatory boundaries. Additionally, ODA's compliance with the MFRPS will create regulatory synergy between ODA and FDA and provide FDA a more complete and accurate body of information from which to draw in the discharge of its own regulatory goals and objectives. Specific Objectives When fully implemented, the MFRPS will assure that ODA's regulatory foundation of laws and regulations will be equivalent to FDA's foundation. Inspections in Oregon will be conducted by a staff trained, not only in the mechanics of an inspection, but also in the regulatory foundations of food safety. ODA will be better prepared to manage incidences of illness, injury, and associated recalls attributable to foodborne illness. Food establishments will be educated in regulatory requirements and understand what it takes to be considered compliant. Furthermore, when an establishment is out of compliance, the staff will apply appropriate legal enforcement action. ODA-Food Safety will work cooperatively with ODA-Regulatory Laboratory to develop and maintain a food-sampling program, and to improve the processes for regulatory testing. ODA will regularly assess its program standards to ensure compliance in addition to cooperating fully with FDA during its audits of Oregon's program. Critical Barriers Oregon faces three critical barriers to the implementation and maintenance of the MFRPS: 1) limited time resources, 2) insufficient staffing, and 3) an antiquated computer system. The MFRPS is both labor and time intensive. Oregon is currently dedicating 100s of hours in an effort to become compliant. The hours spent in implementing the MFRPS directly impact the regulatory work in Oregon by limiting the time inspectors work in the field. Additional funding through this Cooperative Agreement will remove the most critical barrier to ODA gaining full compliance primarily by allowing ODA to more adequately budget time and resources to the program. In January 2010, the ODA Food Program Manager with primary responsibilities for evaluation and self- assessment of the MFRPS program was hired by the FDA Division of Federal State Relations (DFSR) to work as a MFRPS subject matter expert. As a result, Oregon suffered a loss of expertise and experience. Consequently ODA was forced to remove one of two remaining Program Managers from her regularly assigned duties to take on the task of development and implementation of the MFRPS. ODA's current computer system is antiquated and out of date. It cannot reliably store data, nor can it easily interface with other computer systems. Consequently, ODA has begun the process of upgrading its computer system and has dedicated $1 million dollars to the project. The new system will centralize data from four operational areas into one relational database linking data from the field inspection program, ODA Licensing, ODA Laboratory Services and the FSD main office into a central system. !